Behavioral and neurobiological mechanisms of reciprocal social interactions in Substance Use Disorders

Project Summary
Social interactions are fundamental to our daily lives, shaping our identities, relationships, and societies. These
interactions are complex, involving verbal and nonverbal cues, cultural norms, and individual differences,
typically following a give-and-take dynamic with expectations of reciprocation. However, these dynamics are
disrupted in substance use disorders (SUDs), where higher social integration is linked to lower drug abuse and
relapse risk. As drug use escalates from recreational to compulsive, individuals often experience social
impairment, marginalization, stigmatization, and isolation, which can further promote drug use. Despite the
recognized importance of social factors in SUDs, integrating complex social interactions into neuroscientific
research remains challenging, potentially widening the gap between preclinical research and clinical
applications. To address this, we developed a behavioral model where a resident rat initiates interaction by
pressing a lever to activate cues for the partner, who then reciprocates by pressing another lever, leading to
social interaction. This model aims to mimic human conditions more closely by studying how drug use leads to
progressive social isolation when partners do not reciprocate social interactions, while the drug use itself
becomes increasingly compulsive for the residents. In Aim 1, we will identify heroin-vulnerable rats and
observe their social interactions versus heroin choice as their drug use escalates, predicting that partner-
induced social isolation will increase in compulsive rats, further promoting heroin choice. Advanced machine
learning methods will be used to capture complex social behaviors, with the hypothesis that compulsive rats
will exhibit more 'frustration' behaviors (e.g., self-grooming, time spent by the closed door) compared to low-
compulsive rats that can engage in reciprocal social interactions. Based on preliminary data showing the
involvement of the norepinephrine system in reciprocal social interactions, Aim 2 will use a combination of TH-
cre rats and chemogenetic approaches to manipulate norepinephrine in the locus coeruleus of partner rats.
This manipulation is expected to promote reciprocal social interaction and reduce heroin choice in resident
rats, highlighting the importance of social interactions in SUDs. Unlike traditional studies focusing on drug-
administering rats, this approach demonstrates the critical role of social interaction by performing
neurobiological manipulations on partner rats, ultimately influencing the behavior of the drug-using rats.

Public health relevance
Project Narrative Higher social integration reduces drug abuse and relapse risk, whereas increasing drug use leads to social impairment and isolation, further promoting substance use. We developed a behavioral model in which a resident rat initiates interaction and a partner reciprocates. By integrating behavioral analysis and ethologically relevant machine learning approaches with modern neuroscience tools for causal manipulation, we aim to investigate the behavioral and neurobiological mechanisms that mediate the effects of partner-induced social isolation on drug preference.